Generative multiscale models of biomolecular conformational dynamics: from fluctuations to many-component assemblies

This research program aims to integrate physics-based modeling with artificial intelligence to en-
hance conformational sampling and design of biomolecules, with a view towards understanding self-
organization dynamics in biological systems away from equilibrium. Our laboratory has made significant
progress in developing generative neural networks for protein conformational sampling and designing
state-of-the-art algorithms for molecular discovery. Building on this foundation, the program will pur-
sue two interconnected projects over the next five years: 1) creating computational tools that combine
physics and AI to improve conformational sampling and design of single molecules like intrinsically dis-
ordered proteins, mRNA, and small molecules and 2) modeling and characterizing self-organization
dynamics of many-molecule assemblies using nonequilibrium statistical mechanics. The research will
leverage advanced Monte Carlo techniques, generative pre-trained transformers, and physics-based
molecular dynamics simulations to search chemical space, model conformational heterogeneity, and
bridge spatial scales. A key focus will be developing experimentally-informed minimal models of com-
plex biomolecular assemblies like stress granules, and using generative machine learning to move
seamlessly between spatial scales.
The long-term vision is to build an effective statistical microscope that can provide detailed molec-
ular insights into heterogeneous assemblies that are currently inaccessible to structural studies. This
approach could enable design at the ”systems” level by combining experimentally and computationally
guided small molecule, peptide, and RNA design. The program will work closely with experimental col-
laborators to test predictions and develop new models. All tools developed will be made open-source to
benefit the broader scientific community. Ultimately, this research aims to advance our understanding
of biomolecular structure and dynamics across scales, from single molecules to mesoscale assemblies,
with implications for drug discovery and the engineering of novel biomaterials.

Public health relevance
The biological function of intrinsically disordered proteins and other weakly structured biomolecules, like RNA, is determined by their conformational ensemble rather than any one static structure. This proposal aims to build methods to accurately sample these conformational ensembles, which will contribute to our understanding of general properties of intrinsically disordered proteins, and also how these molecules carry out their diverse biological functions. By integrating these models with coarse-grained models of biomolecular self-assembly, we will shed light on larger scale biological structures that drive cellular organization.